Investigating the interaction of motivational systems

Motivational systems are tightly tuned in nature, however laboratory settings tend to focus attention toward one aspect of behavior for simplicity purposes. Appetite regulation is an extremely vital motivational system and dissecting out the neural circuits regulating this complex process is imperative in our fight against obesity and feeding-associated diseases. Here, we are proposing to study how hunger and satiety signals are associated with other motivational processes such as fear and anxiety. Caged rodents are normally presented with food ad libitum, however to test hunger circuits, mice can be fasted or alternatively hunger-promoting neurons can be artificially manipulated. Mice will undergo various paradigms to strengthen hunger signals and presented with visual, auditory and/or olfactory cues that innately drive anxiety, such as the presence of predatory urine or an intruder animal. Studies such as these will allow us to unravel circuit mechanisms integrating motivational systems such as hunger versus fear. We will use a library of Cre-expressing mice (AGRP, POMC, MC4R) as well as Cre-dependent AAV-vectors (ChR2, hM3dq, synaptophysin) in a number of behavioral paradigms including place preference and sociability tests.